Targeting aberrant circadian regulator in advanced prostate cancer

ABSTRACT
Metastatic prostate cancer (PCa) remains to be one of the leading causes of cancer-related death.
Patients with metastatic castration-resistant PCa or mCRPC often develop resistance to the 2nd
generation therapeutics including enzalutamide and the disease becomes deadly. Like many other
cancer types, PCa tumors display high cellular and epigenetic plasticity that are associated with
therapy resistance and progression to more lethal forms such as neuroendocrine PCs or NEPC.
Circadian rhythm (CR) regulates daily oscillations of major biological processes. Circadian disruption
(CD) is considered as a likely carcinogen. We found that PCa cells lost the normal CR regulation and
that one the CR regulators Rev-erbα/NR1D1 acts as a strong candidate driver of growth and survival
of mCRPC cells. We also found that Rev-erbα is overexpressed and amplified in metastatic CRPC
tumors and that its small molecule antagonists displayed high efficacy in inhibition of growth of several
PCa models. Our preliminary mechanistic studies suggest that Rev-erbα associates with several
epigenetic factors to activate multiple gene programs associated with advanced PCa. We hypothesize
that deregulated CR regulators such as Rev-erbα drives tumor plasticity by establishing aberrant
chromatin structures and that targeting the aberrant Rev-erbα function is efficacious and safe for
treatment of the lethal forms of PCa. In Aim 1 and Aim 2, we will establish the driver role of aberrant
Rev-erbα in tumor plasticity and therapy resistance and define the molecular mechanisms. In Aim 3,
we will use multiple models of therapy resistant CRPC to examine the efficacy of the Rev-erbα
inhibitors in sensitizing the treatment and the mechanism of action in blocking tumor plasticity.

Public health relevance
Prostate cancer remains to be one of the leading causes of cancer-related death in U.S. men, largely due to resistance to current therapeutics. Therefore, there is an urgent need of more effective therapeutics that can provide sustained benefits or cure to the patients. Our studies aim to achieve a relatively thorough understanding of the aberrant role of a circadian clock regulator in driving the lethal form of prostate cancer and offer a new therapy strategy for effective treatment of the lethal form of prostate cancer.